Assembly and Dynamics of Molecular Machines in Genome Maintenance

ABSTRACT To maintain stable genomes, cells carry out an accurate and timely replication program and repair such deleterious DNA lesions as double-stranded breaks, inter-strand crosslinks, and damaged replication forks. Project 1 of the parent NIH R35GM131704 MIRA grant (PI: Spies) investigates the molecular machinery of homologous recombination (HR), a cellular process that provides the most accurate means to repair of these deleterious DNA lesions and damaged replication forks, and thereby contributes to genome stability in normal cells, but also helps cancerous cells to develop resistance to radiation and DNA-damaging chemotherapy. We are building a quantitative description of the central step in HR and its regulation, which will draw on the importance of protein plasticity and conformational dynamics in molecular recognition. Project 2 investigates multipurpose DNA repair helicases and their ability to coordinate DNA replication through difficult to replicate regions, thus also contributing to genome stability. Both projects utilize single-molecule total internal reflection fluorescence microscopy (smTIRFM) to visualize and quantify the dynamic assembly and remodeling of the nucleoprotein complexes coordinating HR and processing of alternative DNA structures. Mass photometry is a powerful new technique that will add a new dimension to our measurements by allowing us to quantify the distributions of the molecular species constituting nucleoprotein complexes. This application requests funds for acquisition of the Refeyn OneMP Mass Photometer, an instrument that uses interferometric scattering (iSCAT, aka iScaMS) for label-free detection of molecular mass of individual macromolecules in solution. This system will facilitate our capacity to perform the experiments proposed in the parent R35 award and will significantly enhance the rigor of our approaches. Mass photometry will be highly complementary to smTIRFM analyses, as it will allow us to directly assess the distributions of oligomeric states of the RAD51 recombinase and its mutants with altered RAD51-RAD51 interface at low, physiologically relevant concentrations we use in the smTIRFM studies. We will be able to quantitatively evaluate how the oligomeric states of RAD51 and heterogeneity of the RAD51- and RPA-containing complexes change with changing the solution conditions (including conditions permitting and restricting ATP hydrolysis, and the presence of small molecule inhibitors that may affect the RAD51-RAD51 binding affinity). We will be able to unambiguously determine the equilibrium dissociation constants for and composition of complexes containing RAD51 and the RAD51-interacting fragments of the tumor suppressor BRCA2, and will follow the formation of the RAD51 nucleoprotein filament in a manner complementary to our smTIRFM measurements. Addition of the single-molecule iSCAT measurements will help us to build a completely new picture of the nexus between perturbations of the RAD51 monomer-monomer interface and the filament properties in HR and during replication.

Public health relevance
PROJECT NARRATIVE Molecular machinery of homologous recombination maintains integrity of the genome by promoting faithful repair of the most genotoxic DNA lesions and faithful genome replication. Understanding the fundamental molecular mechanisms of how recombination is regulated and its dysregulation will reveal features, which can be exploited in developing novel anticancer therapeutics. Mass photometry measurements will determine the oligomeric distributions and composition of the complexes involved in central steps of recombination and will therefore improve our models of the recombination and its regulation.